Assessing mechanisms of brain malformation in SCN3A encephalopathy using stem cell-based models

ABSTRACT
This administrative supplement will be used to support the work of Ms. Sarah Pham, an undergraduate-level,
female scientist of Vietnamese descent who is pursuing a career in the neurosciences. Under the leadership and
mentoring of Dr. Ethan Goldberg (MD, PhD), Ms. Pham will conduct experiments related to the parent proposal
titled entitled “Pathomechanisms of SCN3A-related neurodevelopmental disorder (NIH NINDS R01NS119977-
03). The R01 proposal explores the involvement of Nav1.3 to the excitability of early postnatal neurons and the
role of Nav1.3 in brain development. Ms. Pham’s research will utilize and induced pluripotent stem cell-derived
neural progenitor cell (NPC) model to explore how the SCNA3-I875T variant affects NPC proliferation, migration,
and neurite outgrowth. Ms. Pham will have regular and ongoing mentorship, shadowing, and constructive input
opportunities with Dr. Goldberg- a premiere clinician scientist leading pioneering discoveries in epilepsy research
and treatment who has demonstrated experience mentoring and developing scientists from various diverse and
under-represented backgrounds. She will author lab protocols, procedures, and work product of experiments
conducted under this supplement all of which will be assessed by Dr. Goldberg and colleagues partnered with
this lab. Ms. Pham will maintain an increasing level of independence as a researcher within the Goldberg lab
through this administrative supplement period. She will attend lab meetings, educational seminars and
conferences, and will have opportunities both to learn and to disseminate the findings of her research in through
this supplement. This award will afford her the opportunity to develop skills in rigor and reproducibility that are
critical skills to enable her further development and successful transition to a career in neuroscience.

Public health relevance
PROJECT NARRATIVE This is an administrative supplement request to support the investigative work of Ms. Sarah Pham, a female, undergraduate researcher of Vietnamese descent, in the laboratory of Dr. Ethan Goldberg to enhance her opportunities to continue a career in neuroscience and medicine.